Path B Enhancement of NM Department of Agriculture's Produce Safety Program.

PROJECT ABSTRACT
This Funding Opportunity provides for the enhancement of the State Produce Safety Programs to
ensure the safe production of fresh fruits and vegetables and to enforce compliance with the
requirements of FDA's Regulation “Standards for the Growing, Harvesting, Packing, and
Holding of Produce for Human Consumption” (referred to as the Produce Safety Rule). While
many states may not have sufficient resources on their own, participation in and funding through
this grant opportunity provides the resources to implement and maintain a viable, aligned
regulatory program contributing to a reduction of foodborne illnesses, microbiological hazards
and a nationally integrated food safety system. The New Mexico Department of Agriculture
(NMDA) is eligible to apply for this Cooperative Agreement, Path B.
Over the course of this five-year cooperative agreement, the NMDA will work with the FDA
continuing with the mantra “educate before and while you regulate”. The NMDA will further
develop our infrastructure and capacity to operate a Produce Safety Program in New Mexico.
The programs focus will continue with education, outreach and technical assistance for growers
and regulators. Verification and development of the programs farm inventory will continue to
main focus while enhancing the programs capabilities to share meaningful data with the FDA
and other jurisdictions. NMDA will also continue to develop and refine a regulatory Produce
Safety Inspection, Compliance and Enforcement Program under FDA authority, to the
satisfaction of FDA.

Public health relevance
PROJECT NARRATIVE Funding provided through this Cooperative Agreement will allow the New Mexico Department of Agriculture to continue to develop and refine the Produce Safety program to reach the objectives of the FDA Produce Safety Rule. Such alignment necessitates a significant investment to successfully develop and implement a multi-faceted administrative program in support of the Produce Safety Rule. This grant opportunity provides New Mexico the resources necessary to advance efforts for a viable, aligned regulatory program contributing to a reduction of foodborne illness hazards and a nationally integrated food safety system.